Organelle transport and organization in mammalian oogenesis

In mammalian females, quiescent primary oocytes serve as the ovarian reserve supporting mature oocyte
production and ovarian function. Primary oocytes differentiate in fetal ovaries and remain quiescent for years in
adult ovaries, where a cohort of primary oocytes activates periodically to develop into mature oocytes. Quiescent
primary oocytes undergo cell death continuously, leading to diminished ovarian function in adult females. Here,
we propose to continue our study on how primary oocytes are determined among fetal germ cells during oocyte
differentiation; and mechanisms underlying primary oocytes quiescence and loss in adult ovaries. Our previous
study characterized roles of organelle dynamics in mouse oocyte differentiation and quiescence. We found that
primary oocytes form via organelle transport within germline cysts, in which germ cells derived from the same
progenitor are connected via intercellular bridges. ~20% of the germ cells collect organelles (Golgi, centrosomes,
and mitochondria) from sister cyst cells to become primary oocytes, whereas the rest donate their organelles
and undergo cell death. In the quiescent primary oocyte, enriched organelles organize into a Balbiani body (B-
body), represented by a spherical configuration of Golgi complexes. The B-body is maintained by microtubules
and actin, and regulates oocyte quiescence via RNA storage. These studies have laid a foundation for us to
continue investigating oocyte determination and quiescence with a focus on organelle transport and organization
in the next five years. We will continue our study on how the cell fate of collecting vs. donating organelles is
determined among fetal germ cells. Our recent study suggests that organelle transport in cysts is conducted in
a directional manner and facilitated by intercellular polarity between cyst germ cells. We will define the
intercellular polarity by characterizing patterns of organelle (Golgi and mitochondria) transport, and the
interactions between organelles, actin and microtubules in mouse and human germline cysts using advanced
imaging approaches. We will identify functions of MACF1 (microtubule actin crosslinking factor 1) and
microtubule minus-end-targeting protein CAMSAP3 (Calmodulin-regulated spectrin-associated proteins 3) in
intercellular polarity, organelle transport and oocyte determination using inducible germ cell-specific conditional
knockout mouse models. To further our knowledge of the structure and function of the B-body in mammals, we
will unveil protein and organelle compositions of mouse and human B-bodies by protein profiling and imaging.
We will conduct mechanistic study on B-body-mediated quiescence-senescence-cell death transitions in primary
oocytes by investigating roles of the p53/TAp63 pathway in this process using in vitro ovary culture and mutant
mouse models. We will also test the feasibility of protecting primary oocytes from chemotherapy drug-induced
cell death by preserving the B-body function. Successful completion of the proposed study will advance our
understanding of cell and developmental biology in mammalian oogenesis and have a positive impact on
women’s health.

Public health relevance
PROJECT NARRATIVE In mammalian females, primary oocytes form during fetal ovarian development and serve as the only source supporting mature egg production and ovarian function in adulthood. This research will continue our study on organelle transport-mediated primary oocyte determination, and organelle organization-mediated primary oocyte quiescence and maintenance in mice and humans. The outcome of this study will advance our understanding of mammalian oogenesis and have a positive impact on women’s health.